Endothelial cell dysfunction in cerebral aneurysm pathogenesis

Project Summary/Abstract:
Endothelial dysfunction is highlighted as an early marker of vascular abnormality preceding
cerebral aneurysm formation, but the molecular events behind this transformation remain
unclear. Inflammatory cytokines including interleukin-2 (IL-2) mediate vascular disease, but its
role in cerebral aneurysm pathophysiology is unknown. Our preliminary data indicate that IL-2 is
expressed in human cerebral aneurysm tissue and induces a phenotypic switch in endothelial
cell (EC) function from the maintenance of vasomotor activity, to promotion of inflammation and
matrix remodeling. We have also found that inhibition of the IL-2 target protein mTOR with
rapamycin reduced aneurysm progression and rupture in a mouse cerebral aneurysm model.
Collectively this preliminary data suggests a vital role of the IL-2/mTOR pathway in aneurysm
progression. The objective of this grant is to characterize the role of IL-2 activated mTOR in EC
dysfunction and aneurysm development and progression. The central hypothesis of this
proposal is that IL-2/mTOR inhibition promotes repopulation of EC and decreases inflammation,
which halts aneurysm progression and promotes vascular healing. In this proposal, we will
determine the role of IL-2 activated mTOR in aneurysm formation, progression, and rupture and
define the mechanisms by which IL-2/mTOR promotes EC dysfunction (Aim 1). We will treat
experimental aneurysms with a novel stent delivering controlled release of the IL-2/mTOR
inhibitor rapamycin to determine if IL-2/mTOR inhibition reverses EC dysfunction while
decreasing inflammation (Aim 2). Finally, we will determine IL-2 expression, mTOR activation
and EC dysfunction in human cerebral aneurysmal tissue and intra-aneurysmal blood and if
rapamycin treatment prior to surgery reduces IL-2/mTOR signaling and EC dysfunction (Aim 3).
The proposed research is innovative in that successful completion of this project will determine
the events behind EC dysfunction which lead to aneurysm progression and will help develop
novel minimally invasive therapeutic strategies for aneurysm obliteration.

Public health relevance
Project Narrative: Endothelial cell dysfunction occurs early during aneurysm formation and may contribute to the failure of aneurysm treatment. Upon conclusion of this study, we will have an understanding of the role of IL-2 activated mTOR in endothelial cell dysfunction leading to aneurysm formation, progression and rupture. The expected positive impact of this multi-disciplinary research is that by enhancing our understanding and prevention of endothelial cell dysfunction in aneurysm pathogenesis, clinicians will have novel medical therapies, imaging modalities, and minimally invasive endovascular devices for the successful treatment of cerebral aneurysms.